NONTUBERCULOUS MYCOBACTERIA IN PATIENTS WITH CYSTIC FIBROSIS

The overall objective of this investigation is to determine the impact of nontuberculous mycobacteria on the natural course of cystic fibrosis lung disease in the U.S. CF Centers; and to describe the clinical course of CF patients with NTM.